Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT This project is intended to support Dr. Nusayba Bagegni as an early career cancer clinical investigator and clinical trialist with a focus on breast cancer and developmental therapeutics at Washington University School of Medicine, Siteman Cancer Center to support NCI-funded clinical research activities and training. The Applicant's interest is in designing and conducting early-phase breast cancer clinical trials and identifying predictive biomarkers of response and resistance to improve breast cancer outcomes for those with aggressive breast cancer subtypes and advanced breast cancer. The Applicant is committed to establishing an academic career in clinical research, serving both as site and overall PI for a number of NCI-funded therapeutic and interventional clinical trials. The Applicant is vigorously involved in developing and implementing investigator-initiated trials to address unmet need for aggressive breast cancer subtypes requiring novel therapeutic approaches, as well as trials of therapy efficacy monitoring.

Public health relevance
OVERALL: PROJECT NARRATIVE The Alvin J. Siteman Cancer Center (SCC) at Washington University and Barnes-Jewish Hospital is a NCI designated Comprehensive Cancer Center whose mission is to prevent cancer in the community and transform cancer patient care through scientific discovery. SCC accomplishes this mission through strong research programs, shared resource support, education and training, pilot funding programs, and community outreach. The translational research and scientific discovery facilitated by our seven multidisciplinary research programs and 10 shared resources (11th requested in this application) is driven by the needs of patients in our 82-county catchment area throughout Missouri and southern lllinois.